FY23. SBIR TOPIC 167 PHASE I: ULTRAPORTABLE LAB-ON-A-CHIP BIOSENSOR SYSTEM FOR RAPID POSTMORTEM TOXICOLOGY. PERIOD OF PERFORMANCE: 9/27/23-9/26/24

ULTRAPORTABLE LAB-ON-A-CHIP BIOSENSOR SYSTEM FOR RAPID POSTMORTEM TOXICOLOGY